Structure and Assembly of Membrane Proteins at Tight Junctions

Project Summary
Three families of membrane proteins in the apical compartments of epithelial and endothelial cells govern key
structures and functions across human tissues that include cell adhesion, molecular transport, and cell
signaling. As these membrane proteins bridge the intracellular, membrane, and extracellular spaces, they
interact uniquely with each other and other proteins to assemble intricate ultrastructures. These ultrastructures
regulate molecular transport function between cells at tight junctions and cell/cell communication at apical cell
surfaces, enabling tissues to maintain homeostatic physiology. However, breakdowns in tissue integrity and
cell signaling linked to mis-assembly of these tight junction membrane proteins cause tissue-specific
pathologies like cancers, Alzheimer’s, Parkinson’s, Huntington’s, stroke, food poisoning and inflammatory
bowel disease, renal wasting, hepatitis, and diseases of the skin, eyes, and ears. Therefore, the structures
tight junction membrane proteins employ and the biophysical rules governing their assembly, which are
currently unresolved, remain critical barriers that limit our understanding of the fundamental physiological
processes that these membrane proteins regulate. This lack of knowledge also hinders development of new
strategies to treat disorders associated with their mis-assembly. We propose a multi-disciplinary research
program with specialized focus in structural biology and protein biophysics aimed to determine the structures
and mechanisms of assembly these membrane proteins use to regulate tissue homeostasis. Our program has
advanced integrative approaches, pioneered application of state-of-the-art techniques, and developed new
tools specific to tight junction membrane proteins to achieve these goals. In the near term, our program will
resolve the underlying molecular structures and biophysical principles governing the assembly of a subset of
proteins from each of the three protein families. In the long term, the laboratory intends to provide complete
high-resolution “pictures” of tight junction membrane proteins in functional assemblies. This research has
potential to advance design and application of novel therapeutics to remedy tissue-specific ailments that are
linked to disruptions in tight junction membrane protein assembly and ultrastructure.

Public health relevance
Project Narrative In human tissues, three families of membrane proteins govern assembly of intercellular barriers called tight junctions and assemble with other cell surface proteins to trigger important cell signaling cascades. Mis- assembly of these proteins cause tissue-specific diseases in humans. The goals of this research are to determine the shapes these membrane proteins take and the rules they obey to properly assemble so that new strategies can be developed to prevent their mis-assembly and treat disease.